PROBING ALLOSTERY IN METHYL-LYSINE READER DOMAINS

PROBING ALLOSTERY IN METHYL-LYSINE READER DOMAINS
Abstract: Chromatin is the complex of histone proteins, RNA, and DNA that dynamically packages the
genome within each eukaryotic cell. While cell lineage specific transcription factors clearly play a dominant role
in the control of gene expression, the regulation of chromatin accessibility via post-translational modifications
(PTM) of histones is of great current interest as the opportunities for pharmacological intervention in the action
of the associated proteins are significantly better than in the direct perturbation of transcription factors by small
molecules. The molecular details of chromatin regulation are just beginning to be understood and chemical
biology is poised to play a central role in advancing scientific knowledge and assessing therapeutic
opportunities in this field. Specifically, cell penetrant, high-quality chemical probes that modulate the regulation
of chromatin state are of great significance. The advantages of a small molecule driven approach to exploring
chromatin biology are numerous: temporal resolution; mechanistic flexibility; ease of delivery in cells and
potentially, in vivo; and significantly, a chemical probe may provide an immediate transition to a drug discovery
effort, possibly cutting years off the time between target selection and therapeutic intervention. This impact of a
chemical probe results from simultaneously addressing target ‘validation risk’ (the likelihood that
pharmacologic modulation of the target will have a favorable outcome in a disease) and ‘technical risk’ (the
likelihood that a tolerable molecule that modulates the target can be discovered). While probes often lack some
features required in drugs, their discovery diminishes many target validation and technical risks and creates a
cascade of assays, structural and mechanistic information that is enabling to subsequent efforts focused on
drugs. While high-quality probes are challenging to develop, they are achievable within the resources available
to academic programs, and their creation is a fantastic training experience. To maximize the impact of our
probes, we intend to continue our approach of sharing them without creation of intellectual property.
We have pioneered a target-class probe discovery strategy within the large family of methyl-lysine
(Kme) readers. We have been productive in this area and built momentum for future studies focused on the
allosteric interactions between Kme reader domains, nucleotide binding domains, and the catalytic domains
that regulate chromatin function. During this effort, we have established a network of talented collaborators that
complement our strengths in chemical biology, medicinal chemistry, in vitro assay development, and
biophysics; with strengths in molecular, structural and chromatin biology. Allosteric interactions in chromatin
regulatory complexes are critically important phenomena that create unique opportunities for pharmacologic
intervention. We will focus our future endeavors on this exciting frontier in the Kme reader family.

Public health relevance
PROBING ALLOSTERY IN METHYL-LYSINE READER DOMAINS Project Narrative: Chromatin is the complex of histone proteins, RNA, and DNA that dynamically packages the genome within each eukaryotic cell. Allosteric interactions in chromatin regulatory complexes are critically important phenomena that create unique opportunities for pharmacologic intervention. This research will aim to create high-quality allosteric chemical probes for methyl-lysine reader domains to explore chromatin biology and the therapeutic potential of allosterically modulating these domains.